Core--Biostatistics and data management

DESCRIPTION (provided by applicant): The Biostatistics and Data Management Core for the University of Texas M.D. Anderson Cancer Center Head and Neck SPORE will be a comprehensive, multi-lateral resource for data acquisition and management, designing clinical and basic science experiments, developing innovative statistical methodology, statistical analysis, and publishing translational research generated through the head and neck SPORE program. The Biostatistics and Data Management Core will incorporate sound experimental design principles within each project that will increase the clarity and enhance interpretability of study results. Each project will be provided with tailored analyses, accompanied by novel statistical development as necessary, to reveal apparent and hidden relationships among data. The Biostatistics and Data Management Core will provide expertise in the design of an integrated data management system to facilitate communication among all projects and cores. This process includes prospective data collection, data quality control, data security, and assurance of patient confidentiality. The Biostatistics and Data Management Core will collaborate with all project investigators to facilitate the timely publication of all data collected under the SPORE research program. The main objectives of the Biostatistics and Data Management Core are: (1) To provide the statistical design, sample size and power calculations for each project. (2) To facilitate prospective collection, entry, quality control, and integration of data for the basic science, pre-clinical, clinical, and epidemiological studies associated with the head and neck SPORE. (3) To develop a comprehensive web-based database management system for tracking, distribution, and central repository of all H and N SPORE biomarker data. (4) To provide all statistical data analysis including descriptive statistical analysis, hypothesis testing, estimation, and modeling of prospectively generated data. (5) To generate statistical reports for all projects. (6) To develop and adapt innovative statistical methods pertinent to biomarker-integrated translational head and neck cancer studies. (7) To collaborate and assist all project investigators in the publication of scientific results.